Bioenergetics of time-restricted feeding within the brain-adipose axis

Project Summary:
The increased risk of metabolic disorders in individuals subjected to shiftwork and those experiencing sleep loss
indicate that disruption of day/night behavioral rhythms represents an emerging factor in the linked epidemics of
obesity and diabetes. In mice, consumption of a high fat diet (HFD) leads to increased feeding during the light
period (the normal sleep phase) and disrupted circadian and metabolic rhythms. Conversely, nighttime-restricted
feeding (the normal active phase) has emerged as a dietary strategy to combat obesity and diabetes. We have
recently shown that time-restricted feeding (TRF) with HFD provided only during dark period mitigates obesity
due to increased metabolism of food to produce heat. We have further shown that the molecular clock controls
the synthesis of creatine within adipocytes, fueling a futile cycle of ATP consumption which is required for the
metabolic benefits of nighttime-restricted feeding. However, we have not yet identified the brain signals that
promote increased diet-induced thermogenesis during nighttime-restricted feeding, nor the epigenetic
mechanisms at the level of the adipocyte that are required for circadian control of futile creatine cycling
in response to time-restricted feeding. Here we propose to exploit integrative neurogenetic and circuit-based
approaches in combination with behavioral, bioenergetic, metabolomic, and genomic strategies to examine the
interorgan mechanisms by which the brain-adipose axis drives the health benefits of TRF. Aim 1 will test the
hypothesis that the circadian SCNAVPàDMH neurocircuit drives energy expenditure rhythms to maximize health
with nighttime-restricted feeding. This aim builds upon our finding that AVP cells within the SCN project to DMH
neurons which are important in regulation of energy expenditure and thermogenesis. We will examine the effect
of time-restricted feeding on energy expenditure and thermogenesis following (a) chemogenetic manipulation of
the activity of DMH-projecting AVP neurons and (b) after genetic manipulation of molecular clock activity within
these cells. These studies will identify specific cells mediating communication between the SCN and the DMH
that determine the metabolic benefits of nighttime-restricted feeding. Aim 2 will test the hypothesis that the
adipocyte circadian clock synchronizes thermogenic rhythms with the light cycle through the epigenetic control
of creatine synthesis. We will determine how the brain clock aligns adipocyte circadian cycles with the light-dark
cycle through autonomic stimulation of adipose thermogenesis, and we will elucidate the epigenetic mechanisms
that link clock transcription cycles to rhythms of creatine synthesis. Collectively, these studies will define the
mechanisms through which the brain-adipose axis integrates environmental and intrinsic circadian signals
underlying the healthful response to time-restricted feeding.

Public health relevance
Project Narrative: Obesity is a worldwide epidemic due in part to increased ‘around-the-clock’ access to high fat foods and feeding at the “wrong time” of day, though the environmental and genetic factors driving weight gain with irregular meal patterns are not very well understood. Restricting the consumption of food high in fat to the “correct” time of day in the wake period blunts the development of obesity independently of calories consumed through a mechanism involving enhanced metabolism of food and the production of heat. The present proposal seeks to understand how the brain communicates with adipose tissue to coordinate metabolism with the environmental light-dark cycle and will provide insight into the health benefits of time-restricted eating.